Role of Intrinsic Neuroprotective Signaling in Diabetic Retina

Abstract:
Diabetic retinopathy (DR) is a leading cause of blindness and a common complication of diabetes
characterized by progressive neurovascular degeneration in the retina. Currently effective therapies that can
sufficiently protect retinal neurons from cumulative diabetic damage are lacking. As such, understanding the
molecular mechanisms of diabetes-induced neuronal damage and developing new treatment for DR are unmet
needs. In this project, we seek to address this knowledge gap by defining the role of a multifunctional molecular
chaperone namely p58IPK in retinal neurons in diabetes. Prior work has identified p58IPK as a putative regulator
of eIF2α kinases and an endoplasmic reticulum (ER) chaperone participating in protein translation control and
the protein folding process. Loss of function mutations of DNAJC3, which encodes p58IPK, lead to juvenile
diabetes and multisystemic neurodegeneration in the central and peripheral nervous systems. In pancreatic β
cells, deletion of p58IPK increases endoplasmic reticulum (ER) stress and sensitizes the cells to apoptosis;
however, the mechanisms by which p58IPK deficiency causes neurodegeneration are unstudied and the exact
function of p58IPK in retinal neurons under diabetic conditions remains unknown. Recently, we have obtained
exciting preliminary data using our newly generated cell-specific p58IPK conditional knockout (cKO) mouse
lines. Our results strongly support that p58IPK functions as an intrinsic protective molecule to maintain retinal
function under stress conditions. In this project, we will define the in vivo role of p58IPK in retinal neurons during
DR pathogenesis. We will investigate new molecular pathways by which p58IPK regulates protein and lipid
homeostasis through the integrated stress response (ISR) and UGGT2-mediated lipid glycosylation. Finally,
we will evaluate the neuroprotective effects of targeting p58IPK and its downstream pathways in the diabetic
retina for developing new treatments for DR. Successful completion of the proposed studies will not only
provide novel insights into diabetic retinal dysfunction and neurodegeneration, but also help advance the field
in understanding the pathogenesis of p58IPK mutation-induced multisystemic neurodegeneration.

Public health relevance
Project Narrative: Diabetic retinopathy is characterized by progressive dysfunction and deterioration of retinal blood vessels and neurons resulting in severe vision impairment and blindness. The goal of this project is to investigate the role of a multifunctional molecular chaperone in protecting retinal cells from diabetes-induced protein and lipid stress and cell death thus preventing disease progression and vision loss in diabetic retinopathy.